Neurobiology of the Circadian Clock

PROJECT SUMMARY
A fundamental question in neuroscience is how changes in gene expression are translated into changes in
neuronal physiology, and ultimately into changes in behavior. The brain’s 24-hour timing mechanism, or
biological clock, is a system that is uniquely suited to the study of neural plasticity and the genes-to-behavior
problem. The neural network that generates and drives circadian rhythms in physiology and behavior is
located within the suprachiasmatic nuclei (SCN) of the hypothalamus. SCN neurons exhibit endogenous
circadian rhythms in spontaneous spike frequency, even as single cells in isolation, and within these neurons is
a defined network of “clock genes” that forms autoregulatory transcription/translation feedback loops (TTFLs)
to generate near 24-hour rhythms.
There are key gaps in our knowledge regarding the mechanisms of SCN entrainment and the pacemaker
plasticity it induces. Unlike rhythms generation, real-time dynamic SCN molecular and neural network
responses during entrainment have been previously un-observable, and thus knowledge is limited regarding
the actual dynamic topologies of entrainment at those levels. We have developed and instituted novel methods
enabling direct observation of SCN molecular and neural network entrainment topologies using an approach
that combines ChrimsonR optogenetic manipulation of clock neuron electrical activity with PER2::LUC real-
time reporting of clock gene activation (EX vivo CIrcadian Timing and Entrainment, EXCITE). EXCITE provides
precise timing, duration and intensity of recurring input stimulation to the isolated SCN, and tracks SCN clock
molecular rhythms at high temporal and spatial resolution for 3-5 weeks ex vivo. The isolated SCN in this
system strikingly recapitulates canonical features of circadian clock entrainment in intact animals, including
light-like phase responses with period after-effects, period matching and systematic phase angle differences to
stimuli that deviate from 24 hours, and differential entrainment to photoperiods with a minimum tolerable night.
We will use EXCITE to examine - (1) Molecular and Neural Network Topologies for SCN Entrainment and
Plasticity, (2) SCN Neural Network Topology of Entrainment, and (3) Molecular Mechanisms of Photoperiod-
Induced SCN Network Plasticity. Successful completion of these aims will provide novel insight into SCN
entrainment and plasticity - how the SCN molecular and neural networks are modified by light input to result in
behavioral plasticity. Defining the mechanisms by which the SCN encodes light history and photoperiod will
open the way for manipulation of SCN neural and transcriptional networks to ameliorate circadian disorders.

Public health relevance
PROJECT NARRATIVE The brain’s biological clock is composed of a group of nerve cells that generate 24-hour rhythms through the action of clock genes to time the sleep/wake cycle and many other bodily processes. There are many human health conditions that are associated with dysregulation in clock function, including sleep abnormalities, schizophrenia and depression, metabolic syndrome, and age-related circadian disfunction. This research seeks better understanding of how light input that sets the brain clock affects its long-term function, and will identify biological mechanisms by which the plasticity of the clock may contribute to disease processes and could be corrected through optogenetic or gene manipulation interventions.